Elucidation of the Role of Chlamydial ClpX During Development and Differentiation

PROJECT SUMMARY
Chlamydia trachomatis is the leading cause of bacterial sexually transmitted infection both domestically
and globally, with the rate of cases per 100,000 increasing every year. However, infected individuals often fail to
seek treatment largely due to the asymptomatic nature of approximately 70% of infections. Unchecked, chronic
infection can lead to numerous sequelae, including ectopic pregnancy and tubal factor infertility in women or
epididymitis and sterility in men, and those who do receive treatment are typically prescribed broad spectrum
antibiotics. Given the steadily increasing case rate of infections, the risk of chronic issues, and the limited options
for antibiotic stewardship, a more comprehensive understanding of chlamydial biology to produce a more
targeted therapeutic treatment is critical.
Despite having a highly reduced genome, Chlamydia undergoes a complex developmental cycle in which
the bacteria differentiate between two functionally and morphologically distinct forms: the infectious, non-
replicative elementary body (EB) and the non-infectious, replicative reticulate body (RB). An EB initiates infection
by binding to and inducing uptake into a host cell. Within the cell, the EB undergoes primary differentiation into
an RB, which will then give rise to a population of RBs. At an unknown signal mid-developmental cycle, newly
formed RBs will undergo secondary differentiation from RB to EB. The transitions between EBs and RBs are not
mediated by division events that re-distribute intracellular proteins. Rather, both primary (EB to RB) and
secondary (RB to EB) differentiation likely require protein turnover. As such, we hypothesize that ClpX plays
a critical role during chlamydial differentiation through targeted protein degradation. To test this
hypothesis, we generated numerous constructs for overexpression of various mutant ClpX isoforms in
Chlamydia. The overarching goal of this proposal is to delineate a mechanism of ClpX-mediated degradation of
substrates through adaptor dependent or independent means, which may uncover a network of targets that
contribute to chlamydial differentiation. Previous in vitro characterization of these mutations from other labs
studying other bacterial ClpX paralogs allows us to take a more targeted assessment of ClpX function rather
than standard alanine scanning. Aim 1 will determine in which facets of chlamydial biology ClpX plays a role by
observing the effects that these mutant proteins exert on chlamydial development, differentiation state, and
morphology. The proposed experiments of Aim 2 will identify targets of chlamydial ClpX, which will provide
significant insight into its substrate recognition and processing. We have developed a chemical crosslinking
approach combined with Click-iT labeling of chlamydial proteins, specifically, to maintain complex stability when
performing affinity purification of ClpX and its adaptors and substrates. Collectively, these experiments will
uncover the role that ClpX serves in Chlamydia, which in turn will provide mechanistic insight into chlamydial
differentiation and will open the door to targeted therapeutic strategies.

Public health relevance
PROJECT NARRATIVE Chlamydia trachomatis differentiation during normal development is a hallmark of the chlamydial developmental cycle, but we have yet to determine the molecular mechanism for either a key signal triggering the event or the proteomic remodeling during the transition. This work will further our investigations of the role of chlamydial ClpX as a key contributor to these processes by defining not only the effect of systematic mutation of ClpX on bacterial development but also by identifying the substrates of ClpX during the developmental cycle. The proposed studies will provide critical insight into one of the most crucial aspects of chlamydial development, opening the door for downstream targeted therapeutic development, thus lowering our dependence on broad spectrum antibiotics for clinical treatment.